Engineered probiotic bacteria for colorectal cancer immunoprevention and interception

PROJECT SUMMARY
Synthetic biology is driving a new era of medicine through the genetic programming of living cells. One particular
focus has been the engineering of bacteria as therapeutic delivery systems to selectively release therapeutic
payloads in vivo. Since colorectal cancer (CRC) initiation and progression are significantly influenced by
interactions between intestinal microbes and the mucosal immune system, these interactions can be specifically
modulated with engineered probiotics for immoprevention and interception.
Our laboratories have demonstrated that a probiotic bacteria, E. coli Nissle 1917 (EcN), when orally
administered, selectively colonizes colorectal polyps and adenomas versus normal tissue in murine models, and
colonizes tumors in CRC patients. We additionally demonstrated that engineered EcN can produce diagnostic
or therapeutic moleclues in a model of early stage CRC. This UG3/UH3 proposal aims to expand upon this
approach by engineering EcN to identify precancerous lesions, characterize novel stage-specific immune
targets, and rationally design immunomodulatory strains for CRC prevention and interception.
In the UG3 Phase, we will employ a tamoxifen-inducible model of biallelic adenomatous polyposis coli (APC)
gene deletion (ApcFl/FlCdx2-CreERT2) to characterize the dynamics of CRC stage-specific EcN colonization and
immune cell infiltration/activation. We will construct a library of violacein-producing EcN to identify multiple stages
of CRC, from precancerous adenoma to invasive carcinoma. We will then determine the kinetics of adenoma
progression following biallelic deletion of Apc and assess the ability of EcN to colonize precancerous and
cancerous lesions. Additionally, we will characterize the immune cell repertoire of EcN-colonized precancerous
lesions of varying stages using spatial transcriptomics.
In the UH3 Phase, we will design and engineer immunotherapeutic bacteria for CRC prevention and
interception. We will create EcN strains expressing inflammatory payloads (e.g., GM-CSF and IFNg) and deliver
them to mice prior to Apc deletion to determine if EcN-based immunotherapy can prevent the development of
neoplastic lesions. Furthermore, to intercept CRC progression, we will design EcN strains expressing
immunomodulatory payloads (e.g., GM-CSF and anti-CTLA-4 and anti-PD-L1 blocking nanobodies) and deliver
them to mice after verifying the presence of precancerous polyps. Finally, we will examine the durability of the
immune response elicited by engineered bacteria by challenging mice with organoids reflective of advancing
stages of carcinogenesis.
The overall goal of this proposal is to develop effective probiotic-based immunotherapies that prevent and
halt CRC progression by harnessing the power of engineered EcN strains. These novel approaches have the
potential to significantly improve CRC outcomes and provide new avenues for cancer prevention and
interception.

Public health relevance
PROJECT NARRATIVE This project aims to engineer a strain of probiotic bacteria, E. coli Nissle 1917 (EcN), to identify and target precancerous lesions in colorectal cancer (CRC). In the UG3 Phase, the focus is on characterizing the dynamics of EcN colonization and immune response in a tamoxifen-inducible mouse model of CRC, while the UH3 Phase involves designing and testing immunomodulatory EcN strains for CRC prevention and interception. The ultimate goal is to develop effective probiotic-based immunotherapies to prevent and halt CRC progression, ensuring durable immune responses against the disease.